Toward Next Generation Data on Health and Life Changes at Older Ages

Summary
This infrastructure proposal aims to further advance capabilities in the social sciences (broadly defined) to
collect data on the daily lives of U.S. families and individuals. These data will be more accurate, more granular,
and more comprehensive than is currently possible in traditional survey-based research. The context for this is
the Understanding America Study (UAS), the probability-based Internet panel we have been building at USC
since 2014. The infrastructure includes the combination of many data types (including survey data, information
from wearables, contextual and administrative linkages, ecological momentary assessments, self-recorded
narratives, and electronic records of financial transactions), as well as an open communication with the wider
research community both in data dissemination and in soliciting input on content and methods.
The UAS currently comprises about 10,000 U.S. residents, recruited by address-based sampling and
provided with Internet-enabled tablets if needed. Surveys are conducted in English and Spanish. For the coming
project year, we propose to expand the UAS national sample to 12,600 respondents, with oversamples of Blacks,
Asians, and Hispanics, and sufficient representation of rural areas.
Our project aims to create and make available to the research community a uniquely detailed and focused
collection of information on U.S. households and individuals. To achieve this goal, we aim to strategically
integrate selected external data sources with UAS survey data and expand the already broad set of topics
covered by UAS surveys.

Public health relevance
Project Narrative: In the next project year, the project aims to expand the Understanding America Study to a longitudinal study of at least 2,600 individuals, including adequate representation of racial/ethnic groups to power subgroup analysis. Resulting data will constitute a uniquely valuable resource, which will be made available to the research community without delay.